REC

Project Summary/Abstract (REC)
Safety net health care organizations play a central role in caring for medically underserved communities and
vulnerable populations. Conducting high-quality, cost effectiveness research (CER) and patient-centered
outcomes research (PCOR) in these settings is critical to promoting health equity in underserved, vulnerable
groups. However, safety net health systems commonly lack the infrastructure and personnel necessary to
undertake data-intensive research, such as CER and PCOR, and to disseminate evidence-based practices,
including quality performance management, rigorous data capture, analysis, and reporting. In the absence of
research studies explicitly designed to identify and address the unique circumstances and needs of traditionally
underrepresented groups, health disparities in these populations will persist. To support the Southwest Safety
Net Learning Health System in its overall goal to reduce health disparities and improve health equity for
historically disadvantaged populations, the REC will recruit, engage, and train diverse LHS Scholars
embedded in our safety net health systems to conduct inclusive, patient-centered research that improves
outcomes for our most vulnerable and promotes sustained practice change. The REC will support the System
by providing mentorship and training that is personalized to the needs, experiences, and goals of each Scholar
and building a broader network of clinician, the “Rapid Implementers”, who become champions for translating
generated CER and PCOR evidence into practice. Our team is uniquely qualified to lead this effort. Led by
faculty with extensive experience leading and engaging in research training and mentoring programs, the REC
will build on ASU’s past experience as a PCORnet partner to develop a strong personalized training and
mentoring program for Scholars embedded in the under-resourced institutions in our community. ASU faculty at
CHS and beyond have extensive experience mentoring and supporting trainees at all levels, and our safety net
organization partners have a long-standing history of leveraging PCOR and CER principles. Building on ASU’s
world-class educational infrastructure in systems science, informatics, data science, ethics, health equity, and
dissemination and implementation science, aligned with our extensive network of safety net partnerships, we
will prepare a cadre of Embedded LHS Scholars to lead patient-centered outcome research focused on
improving health equity among high-risk priority patient populations. In parallel, we will develop a diverse,
inclusive network of LHS champion clinicians, “Rapid Implementers'', who will be trained to implement PCOR
and CER in clinical care delivery through experiential learning and immersion opportunities. Supported by an
excellent mentoring and training infrastructure, Scholars will conduct research within the context of safety net
institutions, ensuring that the evidence generated is built with and for underserved populations, and
encompasses principles of equity, inclusion, and accessibility.